Tunable multi-timescale cortical dynamics: fundamental theory and practical tools

Healthy cerebral cortex function requires population neural activity that is coordinated across a
wide range of timescales. Neural circuits must operate with quick, momentary sensorimotor
responses (~10 ms), but also maintain persistent activity for short-term memory (~10000 ms),
and many other timescales between these extremes. Depending on behavioral context, faster or
slower timescales may be more useful, but there is no single most-important timescale. The
status quo in computational neuroscience is to pick one particular function (usually associated
with one, or a few particular timescales) and then build theory and experiments which address
it. While useful, this cottage industry approach leaves open an important knowledge gap; we lack
a unified theory that accounts holistically for the many timescales that coexist in real cortical
circuits. How can a single, local population of cortical neurons generate dynamics with a broad
repertoire of coexistent timescales? How is the repertoire of timescales tuned to accommodate
behavioral context? Here we propose to develop fundamental theory and data analytic tools to
answer these questions and to directly test important hypotheses in awake mice. Our preliminary
theoretical efforts and experimental data strongly support the following hypotheses which frame
our proposed work. Central hypothesis 1: Neural populations in awake cortex manifest with a
very broad repertoire of timescales because they operate near criticality, which is a dynamical
regime defined by an infinite range of scale-invariant timescales. Central hypothesis 2: Changes
in arousal and behavior tune the cortical operating regime around criticality, allowing the system
to shift the repertoire of timescales to be faster or slower. Our proposed work will be organized
into four specific aims. In Aim 1, we will develop a temporal renormalization group theory (tRG)
for describing and explaining the origins of multiple timescales in local cortical population spike
recordings. Our theory will build upon traditional RG from physics, but specifically modified for
spatially local, high-density recordings with single cell resolution. In Aim 2, we will generate an
easy-access data analysis toolbox for investigating the timescale repertoire of spike
recordings. In Aim 3, we will determine how timescale repertoire shifts with vigilance and
behavioral context. In Aim 4, we will identify biophysical mechanisms which impact the timescale
repertoire. Our theory and tools will perform fair comparisons of multiple competing theories
(criticality and others) based on a holistic view of cortical timescales. We expect our results to
unify and differentiate the zoo of different possible explanatory models for the timescale repertoire
of cortical population dynamics.

Public health relevance
Proper brain function requires neural activity in the cerebral cortex with a broad repertoire of intrinsic timescales, from a few milliseconds to many seconds. Determining the fundamental origins of cortical intrinsic timescales and mechanisms that tune the repertoire of timescales is important for advancing understanding of the brain in health and in brain disorders. The research proposed here meets this challenge by developing new theoretical approaches and user-friendly data analytic tools that holistically account for multiple timescales and applies these tools to gain insight on how the brain changes as we awake from sleep and become alert.